HSR&D Research Career Scientist Award Application

Dr. Wagner is a highly productive VA health economist who is tackling high-impact and persistent problems in
the VA health care system for which health services research might provide meaningful insights and solutions.
Dr. Wagner directs the Health Economics Resource Center (HERC) and is the Associate Director of the Palo
Alto Center of Innovation, known as the Center for Innovation to Implementation (Ci2i). He devotes 8/8ths of his
time to research related activities, which includes research, mentoring, and service.
Dr. Wagner's scholarship places him among the top health economists in the nation. He has authored over
150 papers and chapters, 122 of which were peer-reviewed. His research has been published top journals
including New England Journal of Medicine, JAMA, Journal of Health Economics, and Health Services
Research. He is frequently sought out by junior and senior researchers, who value his insights, expertise and
perspective. Dr. Wagner has been affiliated with Stanford University since 1999. Starting in November 2016,
Dr. Wagner was appointed as an Associate Professor of Research in the Department of Surgery at Stanford
University.
Dr. Wagner's RCS research plan focuses on three interrelated themes: health information, value and
efficiency, and access. During the RCS, Dr. Wagner will write three proposals. The first proposal seeks to
understand clinician behavior in response to new information about high value care. Cost-effectiveness
analyses often fail to change clinician behavior and we need to understand why if we want to change behavior
and improve patients' outcomes by redirecting the up to 30% of spending that is deemed of little or no value.
The second proposal seeks to develop new performance metrics that identify which VA medical centers are
providing high value care. Currently, performance metrics focus on either process quality indicators (e.g.,
hospital acquired infection) or on resource use (e.g., readmission or length of stay). There are no performance
metrics that consider both quality and costs. Such metrics will be necessary to ensure that facilities are
simultaneously trying to improve patient outcomes while wisely managing their resources. Finally, the third
proposal will focus on access to care and whether the large growth in telemedicine is acting as a substitute or
as a complement for face to face care. Understanding this distinction is critical if the VA is seeking to improve
access within a limited budget. The three aims are integrated in their focus to identify high value care and then
create incentives that reward the delivery of high value care.
Dr. Wagner's RCS award also outlines ambitious plans for service and training. In particular, Dr. Wagner is
developing and pilot testing a “data bootcamp” curriculum. The two-day bootcamp is designed to orient VA
and Stanford researchers to VA data opportunities and potential methods for answering research questions.
The RCS will enable Dr. Wagner to finalize this curriculum and then work with VIReC to disseminate the
curriculum more broadly.

Public health relevance
My research focuses on health information, health care value and efficiency, and access to care. I will use the research career scientist (RCS) award to explore three novel areas. First, I plan on studying how clinicians react to new information that establishes new best practices. The Institute of Medicine estimates that 30% of health care is low value and could be cut with any adverse effect on patient outcomes. Understanding why clinicians do and do not respond to new information is critical if we seek to improve outcomes and reduce costs. Second, given that consumers are sensitive to cost and quality information, I am interested in developing new performance metrics that measure value based on who uses the VA. Third, I am interested in access to specialty care and concerned about how the VA Choice Act is affecting Veterans. My proposal explains in more detail my research plans and my interest in mentoring and service.